Smart environment technology for longitudinal behavior analysis and intervention

DESCRIPTION (provided by applicant): The world's population is aging and the resulting prevalence of chronic illnesses is a challenge that our society must address. Our vision is to address this challenge by designing smart environment technologies that keep older adults functioning independently in their own homes as long as possible. Smart environments have been used as the basis of monitoring activities for residents with health conditions. However, there is currently a lack of large scale, longitudinal research to identify early markers of dementia and other health status changes and to predict functional decline. The objective of this project is to perform a 5-year longitudinal study of older adults performing daily activities in thir own smart homes. By tracking residents' daily behavior over a long period of time our intelligent software can perform automated functional assessment and identify trends that are indicators of acute health changes (e.g., infection, injury) and slower progressive decline (e.g., dementia). By implementing prompt-based interventions that support functional independence and promote healthy lifestyle behaviors (e.g., social contact, exercise, regular sleep), we can improve overall health and well- being. We hypothesize that smart home technologies can be used to detect and predict functional change, to slow functional change and extend functional independence, and to improve quality of life in elderly individuals who are at risk of transitioning to MCI and t dementia. This hypothesis has been formulated on the basis of preliminary data produced by the applicants which supports the efficacy of using smart home technologies for both functional status assessment and for prompting the initiation and completion of activities in individuals with MCI and dementia. The rationale of the proposed work is that understanding the natural history of functional change between aging and dementia will lead to early prevention and proactive interventions that will slow functional change, thereby delaying nursing home placement and cost of care to society. We plan to pursue the following specific aims: (1) Characterize the daily lifestyle of smart environment residents through minimal-supervision activity recognition and activity discovery, (2) Design software algorithms that detect trends in behavioral data, and (3) Evaluate the efficacy of activity-aware automated prompting technology for extending functional independence and improving quality of life. The proposed work is innovative because it will track a large number of individuals longitudinal in their own homes and determine whether this technology can be used to promote healthy lifestyle behaviors and detect health care changes that may lead to early interventions, improved quality of life, and decreased health care utilization. The project is significant because it will introduce new technologies for activity discovery and tracking that require minimal- supervision, contribute algorithms that predict cognitive decline and signal more acute health status change, and demonstrate for the first time that activity-aware automated prompting technologies can be used to support and/or slow functional change and to increase quality of life in elderly individuals. PUBLIC HEALTH RELEVANCE: The proposed study represents the first large-scale, longitudinal investigation of smart environment technologies for in-home functional assessment and intervention. The result of this research will be software algorithms embedded in everyday environments that monitor and assess trends in functional performance as well as automated technologies for activity-aware prompting interventions. This work is relevant to public health because understanding early indicators and predictors of health status change and developing activity- aware automated technologies will have important implications for early prevention, proactive intervention, and treatment that will extend the amount of time individuals can live independently in their own homes.

Public health relevance
The proposed study represents the first large-scale, longitudinal investigation of smart environment technologies for in-home functional assessment and intervention. The result of this research will be software algorithms embedded in everyday environments that monitor and assess trends in functional performance as well as automated technologies for activity-aware prompting interventions. This work is relevant to public health because understanding early indicators and predictors of health status change and developing activity- aware automated technologies will have important implications for early prevention, proactive intervention, and treatment that will extend the amount of time individuals can live independently in their own homes.